Robust and Interpretable Multi-modal AI/ML for Precision Medicine

Project Summary
Biomedical research increasingly leverages multi-modal data, including genomic, multi-omics, medical
imaging, and clinical narratives, to advance precision medicine. The integration of these diverse data types is
significant because it enables a comprehensive understanding of complex diseases, such as cancer and
Alzheimer's disease, by combining the genetic, physiological, and clinical aspects of patient health. Such rich
multi-modal data offer unparalleled opportunities for advancing precision medicine and improving health
outcomes. However, the field faces several daunting challenges: (1) Complex and Heterogeneous Modalities:
The integration of complex data types, such as high-dimensional genomic data and high-resolution medical
imaging, is challenging due to significant noise and data misalignment, necessitating sophisticated data
imputation and denoising methods. Moreover, significant multi-modal interference and suboptimal integration
performance arise from substantial data heterogeneities, which is one of the key limitations of existing multimodal
methods. It necessitates innovative use of advanced regularized optimization and network architecture
designs to alleviate such issues. (2) Reliance on Single-Modality and Incomplete Multi-Modal Data: Traditional
and emerging multi-modal frameworks often fail to effectively synthesize complex datasets. Single-modality
approaches miss interconnected insights, while multi-modal methods struggle with cross-modal interactions and
optimal performance, especially lacking the ability to cope with incomplete or missing multi-modal data that are
ubiquitous in practice. (3) lnterpretability: Existing multi-modal models often neglect essential cross-modal
interactions and rely on posthoc explanations, lacking mechanistic interpretability. To bridge these significant
gaps via a novel multi-modal learning framework, we propose the following aims. Aim 1: To illuminate the black
box of biomedical multi-modal data fusion: Toward effective and interpretable multi-modal biomedical Al. Aim 2:
To address incomplete biomedical multi-modal data via retrieval-based methods: Toward robust multi-modal
clinical classification and prediction. Aim 3: To bridge missing modalities in multi-modal biomedical data via
optimization-based methods: Toward flexible integration with arbitrary modality combinations. Aim 4: To assess
and validate the proposed multi-modal learning framework through integrative analysis of ADNI data for
Alzheimer's Disease and TCGA data for cancer. Throughout the experiments, to verify our proposed methods,
we will use performance metrics like ACC, Macro-F1, ARI, c-index, and AUROC, evaluating them on datasets
including ADNI, Patch-seq GABAergic neuron, multi-omeATAC + gene expression BMMC, TCGA, ABIDE, and
Duke Breast. The proposed methods are expected to accelerate biomedical research and improve healthcare
by enhancing multi-modal data integration, overcoming analysis challenges, and providing valuable insights into
the molecular and physiological processes underlying complex diseases, leading to more effective and tailored
therapeutic strategies.

Public health relevance
Project Narrative Multi-modal integration in biomedical research offers unique opportunities to advance precision medicine by combining multi-omics, medical imaging, and clinical narrative data. This project seeks to develop robust and interpretable AI/ML models for the integration of incomplete multi-modal biomedical modalities. The proposed methods will mitigate the challenges of data heterogeneity, and incomplete or missing data, which are expected to increase the power and rigor of integrative multi-modal analysis of biomedical data, and provide deeper insights into complex diseases such as cancer and Alzheimer's disease.